Investigating neural predictors of real-world social attention in autism during naturalistic social interactions

Project Summary
The field of autism research lacks objective measures of social attention that reflect how autistic people look at
real human faces. Altered social perception in autism, including delayed neural response to faces and reduced
social attention, is almost exclusively understood in relation to static face images in computer-based settings.
For this reason, our current understanding of social attention and its putative neural mechanisms lacks ecological
validity and is dissociated from the context in which clinical differences in autism are observed. This reliance on
images instead of real faces may reduce sensitivity to detect and may even mask real differences in social
attention between autistic and neurotypical individuals, complicating elucidation of underlying neural
mechanisms and parsing of clinical heterogeneity. In this proposal, we address these limitations of prior work by
using ambulatory eye-tracking technology to investigate visual attention during a novel naturalistic interpersonal
interaction task developed by the PI (the Ecologically Valid Observation of Looking and Visual Engagement;
EVOLVE); in this way, we measure visual attention to real human faces (and its neural predictors) during actual
social interactions. We apply a powerful within-person design to (a) compare this innovative and ecologically
valid approach to well-studied, conventional computer-based assays of visual attention (i.e., the Autism
Biomarkers Consortium for Clinical Trials (ABC-CT) and (b) evaluate relationships to neural mechanisms
indexed with conventional EEG (i.e., the ABC-CT faces N170 paradigm). Participants will include 60 6-11-year-
old autistic and 60 matched neurotypical children. We hypothesize that, relative to computer-based assays, the
bonafide social signals in this naturalistic approach will amplify signal and improve detection of autistic
differences in social attention and relationships to the clinical phenotype. Knowledge from the proposed study
will directly inform theoretical frameworks for understanding visual and neural processing of social information
in ways true to actual autistic experience and will significantly advance the translatability of neural markers of
autism in ways relevant to real world behaviors and clinically meaningful outcomes. This innovative approach
has potential to set methodological precedent for using these more naturalistic technologies to better understand
social behaviors in autism and other neuropsychiatric conditions more broadly.

Public health relevance
Project Narrative This project investigates “real-world” measures of social attention and associated neural predictors in individuals with autism spectrum disorder. This research holds promise for developing novel approaches to studying social attention in autism spectrum disorder and for creating new tools to inform diagnosis and treatment response in autism spectrum disorder.